Determining the mechanisms of extracellular vesicle release, function, and clearance

Project Summary/Abstract
Cells release extracellular vesicles (EVs) that carry signals to alter cell fate or metabolism, promote invasive
behavior, or modulate the immune response. EVs show great potential as diagnostic biomarkers for disease
progression, especially in inflammation and cancer. EVs also show promise as a platform for targeted drug
delivery, given their ability to signal to and be taken up by cells. Furthermore, EVs can be degraded via
phagocytosis, providing metabolites to the engulfing cell. Despite the interest in EVs, basic cell biological
knowledge about EV biogenesis, targeting, cargo transfer, and in vivo function is lacking, largely due to the
challenges of imaging <250 nm vesicles that lack specific markers. We pioneered a novel labeling technique
using degron protection assays to specifically label EVs, which allows us to image EVs in vivo using time-lapse
microscopy. We take advantage of the optical transparency and simple genetics of the worm model system C.
elegans for gene discovery and have established the first molecular pathway describing how EVs bud from the
plasma membrane like viruses. We identified conserved proteins that inhibit EV release in worms and human
cells and have generated genetic tools and quantitative assays that enable us to screen for proteins that
promote EV release. We also used degron labeling to determine how large EVs and cell corpses are cleared
by phagocytosis, revealing novel insights into cargo membrane breakdown and phagolysosomal vesiculation
for degradation. Our goals are to determine the molecular interactions of the proteins we identified that
regulate lipid asymmetry and EV budding, to determine the role of phosphatidylethanolamine lipids in EV
budding, to perform genetic screens using sensitized strains to discover novel proteins involved in EV
biogenesis, and thereby define the molecular regulation of EV release. We also plan to use our specific
labeling technique to track individual EVs to determine how EVs interact with cells and transfer cargo,
providing dynamic insights into their functions from developmental signaling to membrane remodeling. We will
also use larger EVs and cell corpses to study how membrane-wrapped cargos are processed inside
phagosomes, especially the role of autophagy-associated Atg8/LC3 lipidation in cargo membrane breakdown.
Breakdown of the EV membrane in endolysosomes may contribute to EV cargo transfer after uptake. This
work has the potential to transform EV production and targeting for drug delivery, as well as to identify key
players in EV biology that can be targeted to influence viral and metastatic spread, diverse diseases, and
homeostasis. Furthermore, defining the mechanisms of phagocytic breakdown is likely to provide insights into
immune modulation and inflammation. Finally, this work on lipid asymmetry is likely to reveal novel aspects of
lipid regulation during key processes from cell fusion to cell division. Thus, our vision is to discover how EV
release is regulated and use this to determine the functional roles of EVs in vivo while also providing
mechanistic insights into diverse proteins and lipids that regulate membrane dynamics.

Public health relevance
Determining the mechanisms of extracellular vesicle release, function, and clearance Project Narrative Cells release and take up extracellular vesicles during normal development as well as disease, but the in vivo functions of extracellular vesicles are still unclear. This work aims to define how extracellular vesicle budding is regulated, identify how they are processed after uptake, and determine their signaling and functional roles. Our findings will provide fundamental knowledge to design approaches to induce biomarker production, develop efficient drug delivery methods, and influence diseases from inflammation to cancer metastasis to viral spread.